Lysosome Regulation and Signaling in Aging and Alzheimer's Disease

This is an equipment supplement application for a Program Project Grant (P01AG066606, June
1, 2021-February 28, 2026, PI: Zheng, Hui). The overarching goal of the parent P01 is to
investigate the lysosome-to-nucleus signaling pathways regulating lysosomal homoeostasis in
aging and Alzheimer’s disease. The P01 consists of three highly interactive projects and two
scientific cores, which are overseen by an administration and data integration core. One of the
essential components of the P01 is Project 2: A TFEB and V-ATPase-mediated lysosomal stress
sensing pathway in tauopathy. The overarching goal of this project is to investigate a Tau-induced
TFEB lysosome-to-nucleus signaling pathway regulating lysosomal homeostasis and cellular
clearance in physiological and tauopathy conditions and to identify strategies to augment this
pathway for enhanced cellular clearance. This project uses in vitro culture systems and mouse
models and requires extensive immunofluorescence staining and microscopic imaging. We have
relied on our existing EVOS FL Auto microscope for this purpose but it is currently out of order.
Unfortunately, this model was discontinued in 1Q 2019 and replaced by EVOS M7000. Starting
2024, this model was no longer serviceable by the company. Therefore, we are in need to
purchase a new EVOS M7000 microscope with Onstage Incubator to replace the EVOS FL Auto.
This is essential to continue with the studies proposed in Project 2 of the P01. We have discussed
the need with Dr. Barrett who advised us to apply for an equipment supplement.

Public health relevance
This is an equipment supplement application for a Program Project Grant (P01AG066606, June 1, 2021-February 28, 2026, PI: Zheng, Hui). This is needed to pursue the experiments and goals proposed in the P01.